Vaccination with invariant MHC-II-linked accessory antigens for protection from HIV infection

ABSTRACT:
This proposal seeks to test a novel hypothesis and approach towards a vaccine to prevent HIV. We recently
demonstrated efficacy against infection against pathogenic SIVmac251 challenge using an accessory antigen
vaccine and MHC-II presentation system. Initially we proposed that by using a novel and innovative vaccine
design based entirely on conserved accessory antigens, and a novel MHC vectored system that we could
achieve protection from pathogenic SIV infection. Our success using these accessory antigens alone was
remarkable, but not total, as 4/6 animals eventually became infected despite vaccination. However, we now
have amassed evidence that our only mistake was to include tat in the original vaccine, which we now suspect
is (like HIV env and gag) produced in abundance in acute infection to “decoy” and thwart the initial immune
responses to infection, as well as induce pro-inflammatory and type 1 immune response which actually serve
to benefit primary and sustained chronic HIV infection by amplifying the target cells necessary for successful
HIV transmission, and to exhaust or eliminate the most sensitive structural antigen specific T cell
precursors. Not only does this hypothesis explain how HIV infection occurs and is closely followed by a
massive T cell activation, it also explains why the infection results in chronic immune activation, why vaccine
responses to Gag, Tat, or Env are inevitably ineffective, and also why the immune system cannot regain the
control of HIV infection either naturally or after prolonged antiretroviral treatment. If our hypothesis is correct,
this may have dogma changing implications and may lead to an effective vaccine. Our scientific premise is that
prior vaccine candidates have failed mainly because immune responses directed against early and abundantly
produced Gag, Env, and Tat are detrimental to the host, and in fact supportive of viral replication, as they
promote proinflammatory responses that support infection with this CD4+ T cell tropic virus, and induce
primary immune responses to irrelevant antigens. Here we propose that a vaccine designed entirely using
subdominant antigens and antigen fragments that are not “cross presented” (Rev, Vpr, Vif, and a conserved
Env region) presented using an innovative MHC-II presentation strategy, and therefore not exhausted or
contributing to excessive inflammation during acute infection, may overcome these viral mechanisms, resulting
in a protective vaccine that could be effective against all HIV clades and strains.

Public health relevance
NARRATIVE: These experiments are relevant to public health for two reasons. First, they may provide proof-of-concept data for testing an entirely new type of HIV vaccine that could protect against all strains of HIV, and second, that incorporating specific proteins into a vaccine may result in increased rather than decreased rates of transmission due to their pro-inflammatory effects. Here we propose the novel hypothesis that targeting key accessory genes using an innovative MHC-II invariant chain vaccine platform that enhances immune responses to non-dominant peptides, while avoiding responses to dominant peptides, should confer complete protection from HIV infection.